ENDOCRINE PANCREATIC FUNCTION IN RECIPIENTS OF PANCREAS ISLET TX

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The overall goal of this investigation is to characterize the long-term metabolic effects of pancreas transplantation and hemipancreas donation in humans. This on-going project will longitudinally assess the effects of pancreas and islet transplantation and hemipancreatectomy on glucose tolerance, insulin secretion, and insulin action. In addition, the pattern of pulsatile insulin secretion will be examined in hemipancreatectomized donors. This information will be of benefit to current and future pancreas and islet transplant recipients and will provide insights into the role of neural and endocrine modulators in the regulation of pancreatic function and glucose homeostasis.